Targeting Senescence to Mitigate Chemotherapy-induced Functional Decline

PROJECT SUMMARY/ABSTRACT
Advances in breast cancer treatment have resulted in significant survival gains. However, cure or control of
breast cancer is not necessarily accompanied by full restoration of health. We have shown that as breast cancer
survivors age, they experience accelerated chemotherapy-induced functional decline compared to age-matched
survivors not treated with chemotherapy and women without cancer. Chemotherapy-induced functional decline
results in poor quality of life, loss of independence, and premature death. The proposed study builds on our
clinical work showing that cellular senescence is a central process linked to chemotherapy-induced functional
decline. Cellular senescence is a fundamental aging process characterized by cell cycle arrest. Senescent cells
accumulate in aging tissues and secrete proinflammatory factors that drive age-related functional decline. We
have observed that, in breast cancer survivors, chemotherapy induces the persistent presence of high levels of
circulating senescent cells, and that survivors with high senescent cell burden are more likely to experience
chemotherapy-induced fatigue, neuropathy, and functional decline. These data provide rationale for targeting
and reducing senescent cells to alleviate chemotherapy-induced functional decline. In non-cancer populations,
senescent cells can be reduced through use of exercise or senolytics (drugs that ablate senescent cells). Recent
preclinical studies also showed that senolytics combined with exercise yielded a greater reduction in senescent
cells compared to either intervention alone. However, the ability of exercise and senolytics to reduce senescent
cells and, ultimately, improve physical function in breast cancer survivors has not been tested. We hypothesize
that targeting senescent cells via exercise and senolytics in breast cancer survivors will yield independent and
additive effects to improve physical function and reduce markers of biological aging. To test this hypothesis, we
propose a multicenter randomized placebo-controlled trial to test the efficacy of exercise and senolytic therapy
(alone or combined) on physical function and markers of biological aging. We will randomize chemotherapy-
treated postmenopausal breast cancer survivors with diminished function, assessed using the 6-minute walk
distance [6MWD], to 1 of 4 arms: exercise + senolytic; exercise alone; senolytic alone; or control. The primary
endpoint will be the change in 6MWD from baseline to end of treatment (Aim 1). Secondary endpoints include
clinical and biological aging markers (Aim 2). We also will assess the safety and adherence of both interventions.
In summary, as the number of breast cancer survivors rises dramatically (estimated to be >6 million by 2040),
mitigating chemotherapy-induced functional decline is an urgent public health issue and a priority of the NIH.
Successful completion of this trial will establish the efficacy of two targeted treatments to mitigate chemotherapy-
induced functional decline. Given that senescence underlies many mid- and late-life chronic diseases, a safe
treatment that improves physical function would have a major positive impact that extends far beyond oncology.

Public health relevance
PROJECT NARRATIVE Accelerated decline in physical function is a common adverse health effect of breast cancer chemotherapy linked to premature frailty, disability, and death. We hypothesize that targeting senescent cells, using exercise and treatments that ablate senescent cells, will improve chemotherapy-induced functional decline. If our hypothesis is correct, the impact on clinical practice would be substantial and will extend far beyond oncology.